CISPLATIN VS TAXOL AND CISPLATIN IN STAGE III AND IV EPITHELIAL CARCINOMA

The objective of this study is to determine the relative efficacy of regimens consisting of taxol, versus cisplatin and versus a combination of the two drugs in patients with suboptimally debulked epithelial ovarian cancer; to determine which of the three regimens contribute most favorably to progression-free interval and survival; to compare the incidence of the audiologic sequelae and other toxicities arising from either of the three regimens.